Cognitive behavioral theory-assisted virtual reality for chronic cancer pain (VR-CAN): device prototype development and feasibility testing

PROJECT ABSTRACT
Over 50% of patients living with cancer experience pain early in the disease course, increasing to at least 75% of
patients who have progressed to more advanced stages. Opioid therapies remain a cornerstone to chronic cancer
pain management – nevertheless, clinical literature and expert opinion reinforce that maximizing effective, appropriate
non-pharmacologic therapies is critical to achieving the best possible pain control, well-being, and return to
function. Virtual reality (VR) is a rapidly developing technology that can temporarily immerse individuals in a calm,
pleasant environment, and has demonstrated efficacy in acute and chronic pain management settings by providing
distraction from pain and lowering pain sensation. Nevertheless, despite growing evidence supporting the efficacy of
VR-based interventions for analgesia, few data are available that provide an understanding of its role in mitigating
persistent pain in patients with cancer and existing studies have used off-the-shelf VR products that are not evidence-
based or designed to meet the unique and complex needs of patients with cancer pain. This collaboration between
Duke University and MedStar Health leverages experience conducting clinical trials of VR to mitigate cancer pain in
both inpatient and outpatient settings (both sites), expertise in the development and implementation of behavioral
pain and symptom management interventions for patients with cancer (Duke), and experience developing VR
applications for healthcare settings (MedStar). Following the NIH Behavioral Intervention Development Stage Model,
our shared goal is to develop (i.e., patient focus groups, provider and expert interviews, patient beta testing) and pilot
test (RCT N=40) a new VR therapy that integrates evidence-based strategies and is uniquely co-designed by patients
living with chronic cancer pain. Aim 1. Iteratively develop and refine a CBT-assisted VR prototype for patients with
chronic cancer pain (VR-CAN) based on literature and the investigative team’s research and clinical expertise, and
feedback collected via focus groups with patients living with moderate-severe chronic cancer pain from both urban
(Washington DC) and suburban/rural (Durham, NC) communities (n=24) and interviews with providers (n=6;
oncologists, nurses), and experts in the field (N=6; e.g., VR technology, cancer survivorship, non-pharmacological
pain management). Leveraging human factors science, this prototype will then be tested for usability in the lab by
patient participants (N=6), iteratively modified based on feedback, and then at home by unique participants (N=6)
daily for one week. Aim 2. Conduct a randomized controlled trial to examine the feasibility (primary aim),
acceptability, usability, safety, and initial clinical impact (pain, psychological distress, pain self-efficacy, pain
catastrophizing) of the developed VR-CAN prototype compared to a tablet-based two-dimensional video control
group. Aim 3 (Exploratory). Collect and evaluate qualitative post-intervention data on VR-CAN participants’ (60%;
n=12) preferences, thoughts, and feelings about the VR-CAN protocol in order to optimize and manualize the VR-
CAN protocol that can be efficacy tested in a larger, fully powered randomized controlled trial. This work has significant
potential to decrease burden for a cancer population that experiences high symptom burden and disability.

Public health relevance
PROJECT NARRATIVE While chronic cancer pain affecting as many as 75% of patients is typically addressed using pharmacologic interventions, experts and patients alike support maximizing any relevant non- pharmacologic interventions as well, such as cognitive behavioral therapy. Virtual reality, a novel technology that can temporarily immerse users in a calm, pleasant environment, has been increasingly shown to facilitate improvement in different acute and chronic pain syndromes by providing distraction from pain and lowering pain sensation. To address the significant needs of patients living with chronic cancer pain, we propose to develop and pilot test a prototype device that will leverage cognitive behavioral therapy principles to deliver a novel virtual reality pain therapy.